INTERACTIONS OF MAMMALIAN REOVIRUS PARTICLES W/ EXPRESSED REOVIRUS PROTEINS

The goal of this project is to determine the structural and functional properties of protein complexes formed between purified reovirus particles and expressed reovirus proteins. 1. Overexpressed outer-capsid proteins mul and sigma3 bind reovirus cores in a manner that recapitulates outer-capsid assembly in vivo. The consequences of these binding interactions on the structural and conformational properties of the reovirus particle will be ascertained. First, negative-stain EM will be used to assess sample quality, followed by cryo-SEM to obtain high-resolution structural information. 2. Overexpressed reovirus outer-capsid protein sigma3 binds reovirus ISVPs in a fashion that renders these reassembled particles functionally similar to virions. The structurd~of the reassembled particles will be studied by negative-stain EM and cryo-SEM. 3. Overexpressed reovirus nonstructural protein muNS binds reovirus cores. The effects of this binding interaction will be determined by negative-stain EM and cryo-SEM. Studying these three virus-protein complexes by a combination of EM techniques available through the IMR should yield important insights into the assembly, disassembly, and modes of pathogenesis of this enteric virus, whose relatives include the mammalian rotavirus, a major killer of infants in Tbird World countries.